PTS. WITH CUSHING'S DISEASE &NON-ACTH SECRETING PITUITARY TUMORS

In some patients with Cushing's Syndrome, the primary disturbance may be at the level of the hypothalamus. Since hypothalamic hormones cannot be measured in the systemic circulation, such patients will be identified by 24-hour pattern of ACTH and cortisol secretion. The diagnostic accuracy and hypothesis will be evaluated by the response to drug therapy, outcome of pituitary surgery, and natural history of disease.